Functional Fibrinolysis, Thromboinflammation and VTE Risk for Ventilated Children

PROJECT SUMMARY
Critically ill children undergoing invasive mechanical ventilation (IMV) experience elevated rates of hospital-
acquired venous thromboembolism (HA-VTE) but are also at increased bleeding risk. The absence of trial-
derived safety data for thromboprophylaxis and prospectively validated pediatric HA-VTE risk models precludes
the application of universal thromboprophylaxis in critically ill children. Therefore, the development of risk
stratification and predictive models to identify children with the greatest risk of HA-VTE balanced by bleeding
risk is vital to inform risk-stratified thromboprophylaxis trials. This proposal is based on a conceptual model that
greater IMV exposure intensity impairs functional fibrinolysis and results in a thromboinflammatory each of which
confers an increased risk of HA-VTE. Accordingly, the scientific objectives are to determine the impact of IMV
intensity on functional fibrinolysis (Aim 1); identify plasma biomarkers of HA-VTE risk (including select thrombo-
inflammatory cytokines [Aims 2a] and plasma proteomic phenotypes [Aim 2b]); and derive an enhanced risk
prediction model for HA-VTE for children undergoing acute IMV combining fibrinolytic and coagulative function,
IMV parameters, thromboinflammatory cytokines, and prothrombotic clinical features (Aim 3). The three
independent aims will inform risk-stratified thromboprophylaxis trial design and identify pathophysiological
mechanisms that will lead to alternative/adjunctive interventions for this vulnerable population. The K23 training
aims are directly aligned with the complementary expertise of the mentors and the scientific objectives, and
include: achieving a deeper understanding of the role of the coagulative and fibrinolytic system in acquired
prothrombotic states and thrombogenesis (Training Aim 1); acquiring proficiency in the evaluation of
thromboinflammatory pathways and biomarker discovery and validation (Training Aim 2); and obtaining
certificate and practical training in clinical trials to gather the essential skills and knowledge in risk prediction
modeling and the design, conduct and analysis of risk-stratified, biomarker-informed multicenter randomized
clinical trials in children (Training Aim 3). The candidate, Dr. Anthony Sochet, Assistant Professor of
Anesthesiology and Critical Care Medicine at the Johns Hopkins University (JHU) based on the Johns Hopkins
All Children’s Hospital (JHACH) campus, has assembled a team of mentors with internationally recognized
clinical and research expertise in thrombosis, biomarker discovery, advanced risk prediction modeling, and
clinical trials. His career development will include a Certificate in Clinical Trials through JHU and thrombosis
curriculum through the International Society on Thrombosis and Haemostasis. He will be supported by the
extensive resources of the Institutes for Clinical and Translational Research at JHACH and JHU. Through this
K23 mentored career development award, Dr. Sochet will become an independent physician scientist with
expertise in pediatric thrombosis and fibrinolysis, prepared to design, conduct, and analyze multicenter clinical
trials focused on risk-stratified HA-VTE prevention strategies in critically ill children.

Public health relevance
Project Narrative Critically ill children who undergo invasive mechanical ventilation are at increased risk for developing blood clots in the veins or pulmonary arteries (called venous thromboembolism, VTE), which can be life-threatening and cause long-term adverse health effects. At the same time, these children have an increased risk for bleeding, preventing a one-size-fits-all approach to using anticoagulants (“blood thinners”) for VTE prevention. Under a mentored career development award, the proposed work will generate new knowledge on the roles of invasive mechanical ventilation intensity, laboratory measures of fibrinolysis (breakdown of clots as they form), and markers of inflammation in the blood in the development of VTE in these children, leading to the development of a VTE risk prediction model that when combined with the successful achievement of the training aims under this award, will lead to the design of future risk-stratified clinical trials of VTE prevention in critically ill children, including those undergoing invasive mechanical ventilation.